ESTROGEN OR ESTROGEN/PROGESTIN REPLACEMENT THERAPY EFFECT ON GLUCOSE METABOLISM

Although the effects of estrogens on carbohydrate metabolism have been addressed in younger women on birth control pills, the issue has not been studied in post-menopausal women. We hypothesize that post-menopausal diabetic women would greatly benefit from estrogen replacement to control their serum lipid levels and reduce their risk of CAD, with little detrimental effect on glucose control.